Cilia and Valvular Heart Disease

PROJECT SUMMARY
This administrative supplement is based on the current RO1 and focuses on novel mechanisms that are
contributing to fibrosis and arrythmia’s in mitral valve prolapse (MVP) patients. This supplement will focus on the
consequences of a prolapsing valve on LV structure and function with a focus on regionalized LV fibrosis. Our
studies will provide unique opportunities to answer questions about heart-valve diseases that heretofore have
not been possible to answer.
MVP is a serious clinical problem, affecting 2-3% of the human population. Its complications include congestive
heart failure, endocarditis, atrial arrhythmias, and sudden death. There are no known non-surgical cures for this
group of disease. The proposed work capitalizes on genetic data collected from MVP patients, which has led to
uncovering novel mechanisms of valve development and disease pathogenesis. These studies hold great
potential for future remedial or therapeutic insight. Our studies will additionally challenge whether current surgical
guidelines for MVP should be revised.

Public health relevance
Project Narrative Regionalized myocardial fibrosis is commonly observed in patients with mitral valve prolapse (MVP) and is a risk factor for postoperative left ventricular dysfunction, arrhythmias, and sudden cardiac death. The proposed administrative supplements aim to demonstrate a mechanistic link between a prolapsing mitral valve and abnormal mechanical forces that promote regionalized myocardial fibrosis, and will further dissect the cellular, mechanical, and molecular changes that initiate and sustain regionalized myocardial fibrosis in MVP. Completion of this proposal will identify new biological pathways that can be targeted for patient benefit, and lend support for modification of existing surgical guidelines to minimize sudden death and postoperative dysfunction in these patients.